EFFECTS OF HANDS ON HEALING VS TOUCH IN BREAST CA SURVIVORS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Investigate the use of a biofield-based therapy compared to mock healing for the alleviation of fatigue and other common side effects experienced after adjuvant or neoadjuvant therapy for breast CA.